Functional B-cell Epitope Discovery for Arthropod-Borne Diseases

The primary goal of this proposal is the delineation of functional B cell epitopes recognized by potently neutralizing or protective antibodies to facilitate future development of safe and effective vaccines and therapeutics. A second major goal of this project is the
development of correlates relating B cell epitopes with mAb neutralization potency and protection in mouse models of infection. This proposal will focus on arthropod-transmitted flaviviruses and alphaviruses.